Immunomodulatory Functions of Insulin Growth Factor Like Proteins in Skin Inflammation

Background and Innovation: Significant gaps in knowledge exist regarding the molecular and cellular
pathways that cause allergic skin inflammation, a key driver of the inflammatory skin diseases, allergic contact
dermatitis (ACD) and atopic dermatitis (AD). Better understanding disease mechanisms of ACD and AD could
lead to improved treatments and outcomes for Veterans. The preliminary studies for this project identified insulin
growth factor like (IGFL) proteins and their putative receptor, insulin growth factor like receptor 1 (IGFLR1),
whose biological functions remain to be defined, as potential mediators of allergic skin inflammation. These data
suggest IGFLs are cytokines produced by keratinocytes that act through IGFLR1 to promote allergic skin
inflammation and that IGFLs and IGFLR1 could be therapeutic targets. In addition to these key conceptual
innovations, important technical innovations include use of new IGFL and IGFLR1 deficient mouse strains that
will permit investigations into how IGFL and IGFLR1 contribute to mouse models of allergic skin inflammation.
Significance and Impact to Veterans Healthcare: An estimated 75% of the U.S. population is sensitized to at
least one of thousands of potential allergens that cause ACD, and approximately 10% of the U.S. population has
AD. The tendencies for allergen sensitization and AD in adults to persist and the similar prevalence of ACD and
AD in active-duty military and the general U.S. population, support the conclusion that ACD and AD are common
in Veterans. In these diseases, skin itch and secondary infections contribute to a high degree of morbidity that
markedly reduces quality of life. As current therapies are limited, often ineffective, and can cause significant
immunosuppression and other types of morbidity, there is a critical need to better understand pathogenesis in
order to identify more effective, more targeted, and safer therapies. The proposed studies hold the potential to
directly inform development of new therapies for ACD and AD, paving the way to realize and implement
personalized/precision medicine approaches for Veterans.
Path to Translation/Implementation: This project will provide an understanding of how the IGFL/IGFLR1 axis
(select pathway) contributes to inflammatory skin diseases, informing the next stages of translation that would
include confirming the role of IGFL/IGFLR1 in disease and efforts to develop therapeutics targeting this pathway.

Public health relevance
PROJECT NARRATIVE: Allergic contact dermatitis (ACD) and atopic dermatitis (AD) are common, chronic, and often debilitating inflammatory skin diseases and constitute a significant medical problem for Veterans. Better understanding mechanisms of skin inflammation that cause these diseases may lead to new and improved therapies. Allergic skin inflammation is a key driver of pathogenesis in these diseases. This project will study functional effects of the keratinocyte-derived cytokine insulin growth factor like protein (IGFL) and its cognate receptor (IGFLR1) on allergic skin inflammation. The proposed project will use basic science and preclinical models combined with transcriptomic studies to gain a detailed understanding of how the IGFL/IGFLR1 axis regulates keratinocyte and immune cell function during allergic skin inflammation. In so doing, these investigations will determine how modulation of this cytokine axis may be used to treat ACD, AD and other inflammatory skin diseases in Veterans.